The University of Pittsburgh Summer Research Internship Program kidney workshop (SRIP-Kid)

Abstract
Chronic kidney disease (CKD) affects over 30 million Americans leading to estimated annual health care costs
of $40 billion. Moreover, there are few therapies for CKD and only palliative treatments for patients with End
Stage Renal Disease (ESRD), namely dialysis or kidney transplantation. In addition, there is large unmet need
to train the next generation of kidney-based researchers to develop new and effective treatments and cures for
the myriad of kidney diseases. The University of Pittsburgh School of Medicine has many investigators across
multiple departments with NIH funded track records of kidney-based research ranging from laboratory based to
patient oriented research. These same investigators have strong track records of mentoring. We are requesting
funds to provide room, board and a stipend to bright undergraduates that will work with mentors on kidney-based
research. This program will allow students to perform research for a 10-week period over the summer as part of
the Summer Research Internship Program kidney workshop (SRIP-Kid). The pool of diverse undergraduates will
come from a wide range of Universities around the country. This program will be administered by the Division of
Pediatric Nephrology and will include faculty from the Pediatric Nephrology Division, Adult Renal-Electrolyte
Division, and Critical Care Nephrology Department. The major goals of this program will be achieved by providing
novel didactics on renal topics and career advice to participants. Select members of the training faculty will meet
weekly with all students to provide a one-hour didactic session on a renal topic followed by a 30-minute
discussion on a pertinent paper and a discussion about career options as a nephrology researcher. Furthermore,
we will provide research training under the mentorship of world-class kidney researchers. A multimedia platform
has been developed specifically for this program and will act as an interface for future, current and past students.
SRIP-Kid students will be matched with one of the training faculty to pursue a research project. Given the breadth
of the training faculty research interests, students will have the opportunity to work on a laboratory-based project
or a patient oriented research project. At the end of the 10 weeks, the students will present their work as an oral
presentation. Upon completion of this summer program the students will have had exposure to a wide array of
kidney-based research topics, to nationally respected clinician-scientists and PhD scientists, and to a specific
kidney-based research project. Given that decisions about a specialty in medicine and/or research focus often
happen in early stages of training, the intent of this program is to increase the number of trainees that will
eventually become clinician-scientists or PhD scientists in nephrology. We will monitor the student’s future career
decisions through social media platforms related to this summer program.

Public health relevance
Project Narrative This training program aims to engage and train the next generation of kidney researchers. SRIP-Kid students will attend didactic lectures, lab courses and hands on lab experience at the hands of world-class researchers in one of the most prolific and exciting research institutions in the country. We will attempt to train between 13- 15 students per year for the duration of the grant.